Prevention of macular pathophysiology associated with F3 misfolding - Admin Suppl

Section is not required for Administrative Supplements

Public health relevance
Section is not required for Administrative Supplements